Gene-specific Mechanisms of BRCA1 transcriptional Control

ACCOMPLISHMENTS 1) We have found that BRCA1 negatively regulates it own transcription by direct association with its promoter. Genotoxic stress and cell cycle progression cause a release of BRCA1 from the BRCA1 promoter that is associated with relief of repression [2]. 2) By ChiP/Chip we have identified numerous BRCA1-associated genes that play a role in cell cycle regulation, DNA repair, and chromatin structure and imply that BRCA1 could be a master transcriptional switch in control of genome stability. 3) We have identified a BRCA1 associated signature by ChIP/Chip that can predict poor clinical outcome in breast cancer patients.